Role of SIN3a in the epigenetic regulation of the Bone Morphogenetic Protein Receptor Type 2 in pulmonary arterial hypertension

Project Summary
PAH is a fatal disease characterized by the progressive remodeling of the distal pulmonary vascular arteries,
resulting in elevated pulmonary vascular resistance and pulmonary artery pressure, which may lead to serious
complications, such as right heart failure, and ultimately death. Accumulating evidence indicates that endothelial
dysfunction is one of the first triggers in PAH that leads to uncontrolled proliferation of vascular cells, vascular
remodeling, and occlusion of the pulmonary blood vessels. One of the most common pathomechanisms in PAH
is the alteration of the Bone Morphogenetic Protein Type 2 Receptor (BMPR2) signaling in vascular cells. The
loss of BMPR2 function, induced by mutation or a loss of expression, is associated with a severe hemodynamic
profile and poor outcomes in PAH patients. Multiple studies point to the pulmonary endothelium as the cell type
that is most critically impacted by BMPR2 loss in PAH. However, the molecular mechanisms underlying the
regulation of BMPR2 expression and its associated PAH-like phenotype remain largely unknown. Our group has
recently shown that SIN3a plays a central role in the DNA and histone methylation of the BMPR2 promoter in
pulmonary artery smooth muscle cells and the pathogenesis of PAH. However, the epigenetic and transcriptional
mechanisms by which SIN3a regulates the BMPR2 gene in PAEC remain to be elucidated.
proposal are to uncover the role of SIN3a in the pulmonary endothelial dysfunction
Our objectives in this
in PAH, identify the
downstream mechanisms underlying the regulation of BMPR2 expression in PAEC, and evaluate the therapeutic
effects of modified mRNA encoding SIN3a in animal models of PAH. Our preliminary data showed that SIN3a is
significantly downregulated in hPAEC isolated from PAH patients. In vitro, we observed that SIN3a silencing
downregulates BMPR2 expression and signaling while potentiating PAEC proliferation and migration.
Mechanistically, we discovered a novel molecular pathway by which SIN3a modulates BMPR2 levels in hPAECs.
Our data showed that SIN3a overexpression upregulates FOXK2 by repressing Enhancer of Zeste Homolog 2
(EZH2)-mediated histone methylation in the FOXK2 promoter. Ultimately, SIN3a overexpression increases
FOXK2 binding to the BMPR2 promoter and upregulates BMPR2 levels in hPAECs. Based upon these findings,
we hypothesize that the loss of SIN3a impairs BMPR2 expression in PAEC, triggers endothelial
dysfunction and vascular remodeling in PAH. In this proposal, our hypothesis will be tested by pursuing the
following three specific aims: Aim 1) To investigate the role of SIN3a in endothelial cell dysfunction and decipher
the molecular mechanism underlying the regulation of BMPR2 in PAH-hPAEC. Aim 2) To elucidate the effects
of SIN3a deficiency in the onset of PAH in smooth muscle cells and endothelial cells using a dual approach. Aim
3) To evaluate the therapeutic efficacy of SIN3a modRNA in preclinical models of PAH. Defining the regulatory
mechanisms underlying the loss of BMPR2 expression in PAH will be of great relevance. Finally, restoring the
expression of SIN3a in the lungs using SIN3a modified RNA might be a new promising strategy for treating PAH.

Public health relevance
Project Narrative Pulmonary hypertension (PH) is a life-threatening and fatal lung disease, and novel therapeutic approaches directly targeting the vascular remodeling process are critical. Our goal is to define the epigenetic mechanisms underlying the regulation of BMPR2 expression in PAH and characterize the physiological consequences of epigenetic modifications in pulmonary vascular cells. Our findings will be of great public health relevance, as this proposal aims to evaluate the therapeutic potential of a new gene therapy approach, which may cure PH.